Optimizing Lung Cancer Screening Nodule Evaluation

SUMMARY
The goal of this project is to optimize the management of screen-detected pulmonary nodules thus maximizing
the benefits of lung cancer screening. Lung cancer is the most common cause of cancer death in the US. To
curb the burden of this disease, multiple national organizations recommend lung cancer screening with low-
dose computed tomography (LDCT). However, up to one third of screening LDCTs identify pulmonary nodules
but only 1-3% of these are cancers. Screen-detected pulmonary nodules are then followed-up with additional
imaging tests and, in some cases, invasive and potentially harmful procedures. Follow-up and subsequent
work-up procedures account for a large portion of screening-associated unnecessary harms and costs. An
optimal nodule management algorithm should substantially reduce these harms and provide early cancer
detection benefits. However, the optimal management of pulmonary nodules detected during lung cancer
screening is currently unknown. There are differing major guidelines for LDCT screen-detected lung nodule
management. Most widely implemented guidelines focus on nodule characteristics to decide the need for and
type of follow-up. These guidelines fail to incorporate other key patient factors such as age, sex, smoking
history, and comorbidities. Furthermore, additional factors can heavily impact the diagnostic accuracy and
harms of nodule management strategies and ultimately, the benefits of lung cancer screening. These include:
1) risk of lung cancer based on participant and nodule characteristics; 2) cancer aggressiveness; 3) type,
sequence and timing of nodule follow-up; 4) follow-up and biopsy related complications; 5) competing risks of
death (non-lung cancer mortality); and 6) impact of evaluation on quality of life. Furthermore, differences in
smoking patterns, lung cancer risk, and comorbidities among diverse race and ethnic groups are not
incorporated in current nodule management guidelines. In this project, we will use simulation modeling to
efficiently determine optimal algorithms that consider all the issues listed above. We will build a simulation
model, the Multi-Racial and Ethnic Lung Cancer Model (MELCAM), based on a previous modeling framework
used by our team to extensively study various aspects of lung cancer control. The project Specific Aims are to:
1) Derive and validate MELCAM to simulate the management and subsequent outcomes of screening
participants from diverse racial and ethnic backgrounds; 2) Use MELCAM to compare existing nodule
management protocols in terms of overall and quality-adjusted life-year gains and harms; 3) Use MELCAM to
generate nodule management algorithm(s) that consider the impact of both nodule and patient factors on
cancer risk, screening harms, and life expectancy to optimize the types and timing of follow-up procedures;
and 4) Determine the cost-effectiveness of existing and novel follow-up algorithms. Our study is innovative in
applying state-of-the-art modeling techniques and personalized approaches to the optimization of pulmonary
nodule management maximizing the benefits of lung cancer screening in diverse populations.

Public health relevance
NARRATIVE The objective of this study is to improve the performance of lung cancer screening by optimizing the management of screen-detected pulmonary nodules. To do this, we will develop a simulation model, the Multi- Racial and Ethnic Lung Cancer Model (MELCAM), to perform comparative effectiveness and cost- effectiveness analyses to identify optimal nodule management algorithm(s). Our results will reduce harms from false-positive findings and maximize benefits from lung cancer early cancer detection by computed tomography screening.